NUCLEAR PROTEIN CONTENT AND HEAT INDUCED CELL KILLING

The overall goal of our ongoing research is to delineate the mechanisms of cell killing and radiosensitization by hyperthermia, in both acute 43 degree C - 45 degreeC, and moderate, 41 degree C - 42 degree C, temperature ranges. We propose to test one hypothesis on heat-induced cell killing and one on radiosensitization. The first hypothesis addresses the mechanism of S-phase cell killing because S-phase cells are the most sensitive to acute hyperthermia and appear to be the only cells that are killed at moderate temperatures. Hypothesis 1: heat-induced aggregation of proteins to DNA replication factories and/or the altered binding of proteins normally associated with these structures is a key step in S-phase cell killing. For the purposes of this proposal, we will use "protein aggregation" to refer to a process where proteins not normally targeted to a subnuclear structure become bound to that structure due to heat shock. Similarly, "altered binding of proteins" refers to proteins that are functionally part of a subnuclear structure and are solubilized under normal isolation conditions, but coisolate with that structure and/or the nuclear matrix (NM) after heat shock. Hypothesis 2: proteins thermally aggregated or bound to the NM contribute to radiosensitization at 41 degree C by inhibiting or altering DNA repair in a manner analogous to that at 43 degree C - 45 degree C. The specific aims are: 1. Determine if protein targeting sequences specific for DNA- replication-factories affect heat-induced aggregation and/or protein binding to DNA replication factories in vivo. 2. Determine if the association of heat-labile proteins with DNA replication factories sensitizes cells to (or mimics) heat- induced cell killing. 3. Determine if DNA replication factories are a target for heat-induced cell killing at 45 degree C. 4. Determine if DNA replication factories are a target for heat- induced cell killing at 41.1 degree C. 5. Determine if heat- induced alterations in protein binding and/or aggregation to the NM and/or DNA repair complexes inhibit or alter DNA repair and thereby contribute to radiosensitization by 41.1 degree C hyperthermia in a manner analogous to that at 43 degree C - 45 degree C.